Role of EphA1/A2 domain-domain and -membrane interactions for receptor specificity and Blood Brain Barrier dysfunction

Ligand activation of Eph receptors plays a decisive role in cell migration during blood vessel formation and
neuronal axon guidance. Eph receptors can also signal independently of ligands, whereby the migration- and
adhesion-repulsive signaling shifts to a pro-migratory stimulus that contributes to metastasis and drug
resistance in various cancers. Recent studies have substantiated the role of Eph receptors in the dysfunction
of the blood brain barrier (BBB) during ischemic stroke, invasion of pathogenic organisms and the early stages
of Alzheimer’s Disease (AD) and other neurodegenerative diseases. Yet, the molecular mechanisms behind
Eph receptor function remain poorly understood. Eph signaling depends on a variety of inter-molecular and
intra-molecular Eph-Eph interactions which involve portions of the protein structure (domains) but also the
cellular membrane. The overall project seeks to identify key residues in sets of interactions, which are not yet
well characterized, but are likely to be key to the different functional states of the overall protein interactions.
Ephs are unique within the superfamily of transmembrane receptor tyrosine kinases due to their C-terminal 5-
helix folded domain, part of the SAM (sterile alpha motif) adaptor protein family. We and others’ have reported
a novel role of the SAM domain to auto-inhibit EphA2 kinase activity. In preliminary experiments for this
proposal, we discovered that mutations in the SAM domain functionally mimic its complete deletion and can
abolish EphA2 autoinhibition. However, the molecular details of how the SAM domain inhibits the kinase
domain are still missing and will be investigated in Aim 1. EphA2 is cleaved at the cell surface by Membrane-
type I matrix metalloproteinase and γ-secretase, key proteins for AD. However, the structure and function of
these intracellular and extracellular-transmembrane receptor cleavage products are poorly understood. We will
characterize a protein construct encompassing the intracellular region (ICR), which consists of the JM region,
the Kinase Domain (KD) and the SAM domain and another with the two membrane- proximal extracellular
FibroNectin III domains (FN1&2), the transmembrane (TM), the juxtamembrane (JM) region. In aim 2, we will
use these EphA2 fragments to investigate the interaction between Eph domains and with the membrane. This
knowledge is crucial for understanding the hierarchical organization of these regulatory interactions. The
studies will be extended to the EphA1, EphA4 and EphB2 receptors, delineating how specific differences in
domain-domain contacts relate to different levels of kinase activity between the different Ephs. In addition, the
proximity of the Eph receptor Fibronectin domains to the membrane is noteworthy: Our preliminary data for
Aim 3 support the interaction between these domains and Aβ, a key peptide in AD. The structural insights we
pursue are essential for the development of diagnostic and therapeutic agents targeting neuronal and vascular
diseases, including the breakdown of the blood brain barrier in neurodegenerative diseases.

Public health relevance
Recent studies have substantiated role of Eph receptors for the dysfunction of the BBB, as reported in the process of invasion of pathogenic organisms and the early stages of Alzheimer’s (AD) and other neurodegenerative diseases. Yet, the molecular mechanisms regulating Eph receptor function remain poorly understood. To gain insight into the mechanisms of Eph proteins at the molecular level we aim to identify key residues for domain-domain and domain-membrane interactions and configurational changes, primarily in EphA1 and A2, but also in EphA4, B2. The insights obtained will help the eventual development of diagnostic and therapeutic agents.